A Cluster Randomized Controlled Trial Comparing the Safety Action Feedback and Engagement (SAFE) Loop with an Established Incident Reporting System

Project Summary
Substantial progress has been made in some areas of patient safety, but medication errors and other
problems continue to harm many thousands of patients each year. In other high-risk industries, voluntary
incident reporting is widely used to improve safety. Incident reporting is also widely used in hospitals, but the
reporting systems do not function optimally. Nurses file most reports, but they experience multiple barriers to
reporting, including uncertainty about what to report, lack of feedback, and doubt about how hospitals will use
the reports. Nurses submit thousands of reports each year, but the reported incidents represent a lower-risk
subset of medical errors, the reports impart few actionable insights, and no standardized procedures exist for
conducting follow-up investigations. The Safety Action Feedback and Engagement (SAFE) Loop has five key
attributes designed to transform hospital incident reporting systems into effective tools for improving patient
safety: obtaining nurses’ input about which medication safety problems to address; focusing on selected high-
priority events; prompting nurses to report high-priority events during a designated period and training them to
write more informative reports; integrating information from reports, investigations, and other internal and
external sources; and providing feedback to nurses on the problems identified and mitigation plans.
To compare use of the SAFE Loop and an existing incident reporting system, the investigators will
conduct a cluster randomized controlled trial of 20 acute care nursing units at Cedars-Sinai Medical Center in
Los Angeles, where 1980 nurses provide over 294,000 patient-days of care per year. Corresponding to three
study Aims, outcome measures include: (1) incident reporting practices (rates at which nurses report high-
priority medication incidents and numbers of contributing factors described per report), (2) nurses’ attitudes
toward incident reporting (AHRQ Hospital Survey on Patient Safety Culture™, particularly perceptions of
feedback and communication about error and of the frequency with which events are reported), and (3) rates of
high-priority medication events (determined via IHI Trigger Tool method of medical record review). Analyses
will compare changes in outcomes between from before to after implementation in intervention and control
arms. Qualitative interviews of nurses the SAFE Loop arm will provide insight into implementation.
If effective, the SAFE Loop will have several benefits: increasing nurses’ engagement with reporting,
producing more informative reports, enabling safety leaders to understand problems and design system-based
solutions more effectively and more efficiently, and lowering rates of medication errors. In turn, receiving
feedback about problems and system-based solutions will further improve nurses’ perceptions of reporting. In
addition to the local benefits to hospitals that implement the SAFE Loop, these changes will create secondary
benefits nationally by enhancing the functioning of AHRQ Patient Safety Organizations, which rely on incident
reports as critical sources of insights into safety concerns in hospitals and potential solutions.

Public health relevance
Project Narrative In high-risk industries, such as aviation, voluntary incident reporting is a widely used and effective technique through which frontline personnel describe events—particularly near misses—that serve as early warnings of safety problems. Incident reporting systems have existed in U.S. hospitals for over 50 years, but they have not been as effective at improving patient safety. This cluster randomized controlled trial will test whether a novel intervention, the Safety Action Feedback and Engagement (SAFE) Loop, enhances incident reporting practices, improves nurses’ perceptions of incident reporting, and lowers rates of high-priority medication events, as compared with using an existing incident reporting system.